Zebrafish Development and Genetics

PROJECT SUMMARY
This proposal, entitled "Zebrafish Development and Genetics", requests support for an intensive two-week
laboratory and lecture course held at the Marine Biological Laboratory (MBL) for advanced graduate students,
postdoctoral fellows and independent investigators that focuses on the development and genetics of zebrafish,
with special emphasis on the mechanistic basis of embryogenesis, organogenesis, and regeneration. In its
24th year, the MBL Zebrafish course is still the only one of its kind worldwide, covering time-proven and newly-
developed technologies and their applications in zebrafish. Mornings and afternoons are devoted primarily to
laboratory exercises punctuated with interactive workshops, while the evenings are typically spent on data
evaluation, lectures by leading figures in the international zebrafish community, and discussions.
During the first week of the course, students learn concepts and techniques that are crucial for most zebrafish
laboratories working on embryos and larvae: staging and anatomy, microscopy, microinjection, in situ
hybridization, immunohistochemistry and imaging. Emphasis is placed on best practices for achieving rigor and
reproducibility using each approach. The first week also focuses on genetics, with workshops covering genome
editing and web-based genomics resources. The second week focuses on development and function of
various organ systems, including concepts and techniques related to specific developmental disorders and
tissue regeneration. Having been introduced to embryonic, larval, and adult anatomy in week one, students
then learn techniques for labeling, ablating and transplanting cells to assess cell fate, morphogenesis and
regeneration. Emphasis is placed on high-resolution live imaging of fluorescent transgenic reporters, including
quantitative approaches for tracking cell movement and cell shape changes. Additionally, the course teaches
techniques for studying larval visual and locomotor behaviors, including the genes and neural circuits involved.
Throughout the two-week course, laboratory sessions are interspersed with workshop-style roundtable
discussions that cover practical aspects of zebrafish research (e.g. when to select fish as a model organism,
best practices in fish husbandry) and discuss the latest developments in the field (e.g. strategies for disease
modeling, single cell "-omics"). Finally, each of the course faculty presents a lecture centered on their current
research. These highly interactive seminars are considered to be a highlight of the course, as they frequently
nucleate engaging discussions about outstanding biological questions that extend well into the evening.
The MBL Zebrafish course has received rave reviews from previous trainees. It strives both for scientific
excellence as well as to train a diverse and inclusive group of scientists joining the zebrafish community. It is
carefully crafted to provide newcomers to the zebrafish field with training in essential techniques and cutting-
edge strategies used in this system. In addition, by facilitating interactions with leading figures in zebrafish
research, the course creates a fruitful ground for its students to network and develop enduring collaborations.

Public health relevance
PROJECT NARRATIVE Over the past 25 years, the zebrafish has become one of the most prominent model systems in which to study the genetic, molecular and cellular mechanisms underlying embryonic development, regeneration, and disease. This proposal requests support for an intensive two-week laboratory and lecture course held at the Marine Biological Laboratory (MBL) for advanced graduate students, postdoctoral fellows and independent investigators that focuses on the development and genetics of zebrafish, with special emphasis on early embryogenesis, models of birth defects, and regeneration. In its 24th year, the MBL Zebrafish course is the only course of its kind worldwide, and it consistently receives rave reviews from participants, many of whom consider their experience in the course as instrumental in starting their own zebrafish research program.